CONTROLLED TRIAL OF 4 AMINOSALICYLIC ACID (4-ASA) IN ULCERATIVE COLITIS

Examination of the potential therapeutic effect of 4-ASA on patients with ulcerative colitis. This is an FDA "Orphan Drug" sponsored double blind randomized 6 week controlled trial that includes state of the art assessmen of the severity of the disease.